Beta cell Notch activity in Type 2 Diabetes

Project Abstract
β cell mass and function adapts to the insulin requirements of the organism to maintain euglycemia across a
wide range of pathophysiology, such as insulin resistance induced by obesity, pregnancy or aging. Although
molecular mechanisms that enable β cell adaptation to these stressors are not yet fully understood, insufficient
functional adaptation becomes clinically apparent with the onset of Type 2 Diabetes (T2D). With the continued
increase in obesity, novel therapeutically-tractable pathways that regulate β cell adaptation are sought to
reverse β cell dysfunction in T2D.
Notch is a highly conserved family of proteins critical for cell fate decision-making; in the developing endocrine
pancreas, Notch signaling regulates β cell differentiation, but less is known about Notch action in mature
tissue. We have recently shown that Notch signaling is present at low levels in fully developed β cells, but
increased in islets cultured in high glucose or isolated from obese mice. Persistent β cell Notch signaling
appears detrimental to function, as we observed improved glucose tolerance with genetic inhibition of β cell
Notch action. Conversely, forced Notch activation impaired glucose-stimulated insulin secretion (GSIS) in
isolated mouse or human islets, and induced glucose intolerance in β cell-specific Notch gain-of-function mice.
In Aim 1, we investigate mechanism of increased β cell Notch activity, leveraging data showing that β cell
expression of the Notch ligand, Jagged1, tracks with Notch activity. We test whether β cell Jagged1 is
necessary and sufficient for the maladaptive β cell Notch response in obesity. In Aim 2, we address
mechanism of Notch-induced GSIS defects. In key preliminary data, we found that Notch induces degradation
of MafA, a key regulator of β cell maturity disrupted in T2D. We also observe novel MafA acetylations, blocked
by Notch activity. We now study whether MafA stability and activity is dependent on acetylations, and elucidate
the molecular machinery underlying these post-translational modifications. We also test whether Notch impacts
stability and acetylation of the closely related transcription factor, MafB. Finally, in Aim 3, we test implications
of our identified NOTCH-MAFA/B axis in human β cell transcriptional and function response to glucose, as well
as effects on β cell heterogeneity in human islets. Achieving the goals of this application will determine
upstream signals for Notch activation, downstream effectors of Notch-induced β cell dysfunction, and
potentially develop novel therapeutic directions for the care of patients with T2D.

Public health relevance
Project Narrative Type 2 Diabetes (T2D) typically develops in the backdrop of obesity-induced insulin resistance, but manifests clinically as hyperglycemia only with β cell dysfunction. Several T2D therapies increase insulin secretion, but molecular determinants of other aspects of β cell biology affected in T2D – loss of maturity, altered cell-cell and cell-stroma interactions – remain incompletely understood. In this application, we focus on cause and effects of β cell Notch activation, a maladaptive response to obesity that drives β cell dysfunction.